Mechanisms regulating afferent innervation in the dental pulp

Project Summary/Abstract
Since teeth are exposed to environmental stimuli, tooth innervation is crucial to their lifelong protection and us-
age. The tooth is primarily innervated with sensory nerve fibers from the trigeminal ganglion (TG) that help pro-
tect the tooth organ by relaying noxious stimuli. During postnatal development, the dental pulp (DP) secretes
neurotrophic factors to guide axonal penetration and sprouting within the tooth in a highly regulated manner.
The transforming growth factor β (TGFβ) superfamily regulates many developmental processes in teeth, in-
cluding mineralization and innervation. A secreted phosphoprotein downstream of TGFβ signals, osteopontin
(OPN), is a major extracellular protein that regulates tooth mineralization and also promotes neurite outgrowth.
Following tooth injury, DP cells release neurotrophic factors that modulate neurite growth and dentin repair.
Interestingly, OPN-/- mice do not form reparative dentin during pulpal healing, suggesting that OPN plays a cru-
cial role in this process. The long-term goal of this project is to understand the cellular mechanisms that protect
teeth via sensory innervation. The overall objective is to determine the role of signals from the dental mesen-
chyme that regulate tooth innervation. Our central hypothesis is that Tgfbr2 in the dental mesenchyme governs
paracrine signaling via OPN to guide tooth sensory innervation. Our laboratory has established a mouse model
in which Tgfbr2 is conditionally deleted in odontoblast-producing mesenchyme using an Osterix promoter-
driven Cre recombinase (Tgfbr2cko). These mice survive postnatally, but have significant defects in their bones
and teeth. We performed a series of experiments to determine whether Tgfbr2 signaling in the DP mesen-
chyme regulates their differentiation and ability to guide neurite outgrowth during tooth development. We found
that OPN-/- mice do not demonstrate reduced innervation at P7 as originally hypothesized, but do exhibit dis-
rupted axonal targeting. The role of neurite outgrowth in regulating reactionary and reparative dentine when the
mineralization capacity of the DP cells is compromised remains unknown. Guided by these data, we will test
our hypothesis with the following two specific aims: 1) To analyze the OPN-governed signaling cascades in the
dental mesenchyme regulating tooth sensory innervation during development; 2) To establish the degree to
which the neurite outgrowth associated with dentin repair is regulated by Tgfbr2 and/or OPN signaling in the
DP mesenchyme. Under the first aim, we will perform an mRNA Sequence Analysis of control and OPN-/- DP
tissue to determine what signals could be disrupting the afferent organization. In the second aim, we will use
an in vivo dental injury model and investigate neuronal regeneration in Tgfbr2cko, OPN-/-, and WT mice. The
proposed research is significant because it is expected to advance and expand the understanding of how DP
cells protect the tooth organ via mechanisms involving axonal guidance. Such information will enhance our un-
derstanding of the complex interplay of mesenchymal-neuronal interactions in the tooth that could serve as a
basis for future preventive, therapeutic, and regenerative strategies in endodontics to improve the preservation
of teeth.

Public health relevance
Project Narrative Teeth are protected from our daily activities with a high degree of sensory innervation to detect pressure, temperature and pain. We have established a mouse model in which Tgfbr2 is deleted in the dental mesenchyme and found neuronal development and function were highly regulated by the dental pulp. We propose to investigate the mesenchymal-neuronal crosstalk guided by Tgf to enhance our current understanding of tooth development and regeneration and provide new therapeutic targets for pain management and regenerative strategies.